Mechanisms of the Gain-of-functions of p53 mutants and the effects by USP7 PROTAC

Project Summary
TP53 (also called p53) is the most frequently mutated gene in human cancers, and p53 missense mutant alleles
are present in more than 40% of all human tumors. In addition to loss of the wild-type p53 function, some
missense substitutions enable its mutant forms to gain a selective advantage for cancers such as increased
tumor growth and metastatic potential. Interestingly, however, accumulating evidence suggests that different p53
mutants show different gain-of-functions in vivo, challenging the conventional thinking that the p53 mutants share
the same GOFs through interacting with the same cellular factors. In a proteomic screen, we identified a heme
binding transcriptional factor BACH1 as a major cellular factor that recognizes the DNA binding domain of p53
in a manner dependent on its mutation status. BACH1 specifically interacts with p53R175H but fails to bind either
wild type p53 or several other hot-spot p53 mutants. Interestingly, p53R175H acts as a repressor for BACH1-
dependent ferroptosis by abrogating BACH1-mediated downregulation of SLC7A11 expression to promote tumor
growth; conversely, p53R175H functions as a coactivator for BACH1-dependent tumor metastasis by upregulating
pro-metastatic gene expression. Furthermore, we found that the stability of p53R175H is tightly regulated by USP7;
by using PU7-1, a small-molecule USP7 PROTAC degrader, we found that the levels of p53R175H were
significantly reduced upon USP7 degradation. Moreover, USP7 also interacts with other p53 hot-spot mutants,
suggesting that PU7-1-mediated effects on protein stability is a potential general mechanism applied to other
p53 mutants. The central hypothesis to be tested here is whether this p53R175H and BACH1 interaction is crucial
for p53R175H-mediated GOFs in promoting both tumor growth and metastasis and whether destabilization of p53
mutants by PU7-1, effectively abrogates the GOFs of p53R175H and potentially, other p53 hot-spot mutants for
cancer therapy. In Aim 1, we will elucidate mechanistic insights into p53R175H–mediated gain of functions by
interacting BACH1 and USP7. In Aim 2, we will dissect the role of the gain of functions by using different mouse
models and effects by the USP7 degrader in vivo.

Public health relevance
Project Narrative Inactivation of the p53 tumor suppression pathway is a pivotal event in the formation of most human cancers. p53 is the most frequently mutated gene in human cancers, and p53R175H is one of the major hot-spot conformational mutant with well-documented gain of functions in tumorigenesis. The central hypothesis to be tested here is whether the BACH1- p53R175H interaction plays a key role in modulating the gain-of-functions of p53R175H in promoting tumor growth and metastasis.